Colorectal Cancer Treatment and Drug Resistance; the Role of IGF2BP1

ABSTRACT
Advances in chemotherapy treatment regimens for advanced colorectal cancer (CRC) have significantly
improved patient survival, yet drug resistance remains an important clinical challenge that is associated with
poor patient outcomes. Insulin-like Growth Factor 2 mRNA-binding protein 1 (IGF2BP1) is a bona fide
transcriptional target of the Wnt/β-catenin signaling pathway, a central mechanism that drives colorectal
carcinogenesis. IGF2BP1 is unique in that it promotes cell proliferation and induction of MDR1 gene. Further,
we have shown that inhibition of IGF2BP1 sensitized CRC cells to drugs in vitro. Our long-term goal is to
accelerate the development of clinically useful mechanism-based therapeutics for treating colorectal cancer
resistance. The overall objective for this application is to determine the in vivo efficacy of IGF2BP1 inhibition in
the chemotherapeutic treatment of chemoresistant CRC and delineate its mode of action. The central
hypothesis is that inhibition of IGF2BP1 will modulate a set of known and unknown genes unique to resistant
CRC cells to sensitize them to chemotherapeutics resulting in tumor regression. The rationale is that the
determination of the preclinical therapeutic efficacy and associated mechanisms of IGF2BP1 inhibition is likely
to provide strong basis for the development of a new class of drugs for an effective colorectal cancer
treatment. Guided by strong preliminary data, the following two specific aims are proposed: 1) To determine
the effects of IGF2BP1 inhibition in sensitizing chemoresistant colorectal cancer cells to chemotherapeutics in
a human xenograft tumor model; 2) To assess the effects of IGF2BP1 inhibition in sensitizing colorectal cancer
to chemotherapeutics in an immunocompetent and autochthonous model. For the first aim, chemoresistant
CRC cells and a human xenograft tumor model will be used to elucidate the mechanisms by which inhibition of
IGF2BP1 sensitizes resistant CRC cells to chemotherapeutics and determine its efficacy in vivo. For the
second aim, we will use intestinal-specific IGF2BP1 knockout in an immunocompetent and autochthonous
model of CRC to assess the efficacy of IGF2BP1 inhibition in sensitizing colorectal cancer to
chemotherapeutics in vivo. We will also assess the effects of IGF2BP1 inhibition on tumor heterogeneity in this
study. The proposed research is innovative as it proposes a novel approach to treat advanced and
chemoresistant CRC that targets IGF2BP1 to sensitize resistant CRC cells to chemotherapeutics. In this study,
we will also identify the mechanisms by which inhibition of IGF2BP1 sensitizes chemoresistant cells to drug
which is thus far unknown. The proposed research is significant because in vivo, mechanism-based proof of
principle evidence for a preclinical role of IGF2BP1 inhibition in sensitizing resistant CRC to chemotherapy is
likely to inform the subsequent development of novel strategies for reducing resistance in human patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing a new approach to treat advanced and resistant colorectal cancer by inhibiting the function of an RNA binding protein that regulates numerous oncogenic proteins involved in growth and survival of colorectal cancer cells. This would provide a more effective treatment option for advanced chemo-resistant colorectal cancer and potentially reduce colorectal cancer mortality in our communities. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing illness and disability.